Patterning dendritic branches with environmental and neuronal surface molecules

During neuronal development, stereotyped axonal and dendritic arbor shapes are often achieved
through dynamic and stochastic growth, branching and retraction. The shape of arbors are also
determined by guidance receptors and ligands. How guidance receptor and ligands interact to
achieve the proper shape through a dynamic process is unknown. Our previous work funded by
this grant identified that extracellular ligand SAX-7/LICAM dictates the shape of the PVD sensory
neuron through its binding to the dendritic guidance receptor DMA-1. Our current unpublished
results argue against the popular view in the field and support a new model. Unexpectedly, we
find that ligand-free DMA-1 is sufficient to promote robust, stochastic dendrite growth. Our data
also suggest that ligand binding might inhibit growth, prevents retraction, and specifies arbor
shape. We propose that DMA-1 needs to be endocytosed and subsequently reinserted onto the
plasma membrane via recycling endosomes, to generate a pool of ligand-free DMA-1 which is
critical to promote dendritic growth. Therefore, ligand-free guidance receptor mediates intrinsic,
stochastic dendritic growth, while extracellular ligands instruct dendrite shape by inhibiting growth.
Specifically, I propose to test this new model of how ligand-receptor interactions mediate
the dynamic process of dendrite development characterized by stochastic growth and retraction
but ultimately gives rise to arbors with stereotyped shape with three aims. In Aim 1, we will design
specific experiments to dissect the function of the ligand free DMA-1 and ligand bound DMA-1. In
Aim 2, we will understand how the cell biology of dendrite guidance receptor is regulated to
achieve its function. The size of the dendrite is also determined by its interaction with a
neighboring neuron’s dendritic arbor. In Aim 3, we will understand the molecular mechanisms of
dendritic tiling by identify the morphogenetic factor and the dendrite-dendrite interaction that limits
the size of PVD dendrite. In summary, this proposal will systematically address the molecular and
cell biological mechanisms that specify the dendritic arbors.

Public health relevance
Project Narrative Dendrites are highly branched neuronal processes that serve as the “antenna” of neurons to gather information. Understanding how cells use their genes to grow and shape dendrites will provide the basis for developing new strategies for combating developmental neurological diseases such as autism and for slowing down the progression of neurodegenerative diseases such as Alzheimer’s disease. In addition, such knowledge will be helpful for developing strategies to promote the regeneration of neural circuits after stroke.